Language as a Candidate Marker of FXTAS in FMR1 Premutation Carriers

PROJECT ABSTRACT
The FMR1 premutation (PM) affects ~1 in 150 women and ~1 in 470 men in the United States, and can have a
significant effect on physical and mental health. Forty percent of males and 16% of female PM carriers are
diagnosed with fragile X-associated tremor/ataxia syndrome (FXTAS) between 55-60 years of age, though who
will manifest the disease is unknown. FXTAS is characterized by executive dysfunction, gait ataxia, and intention
tremor. In the absence of clear markers of disease progression among PM carriers, it is essential to characterize
language. Language predicts neurocognitive decline in related conditions (e.g., Alzheimer’s) 10-20 years prior
to diagnosis. Language is a promising candidate marker of FXTAS as female PM carriers show age-related
changes in pragmatics and lexical-semantics, which have been linked to executive dysfunction. Executive
function and language difficulties may adversely impact quality of life. No studies to date have examined
language among both male and female PM carriers, limiting our understanding of potential preclinical markers
of FXTAS. As a first step, the proposed project will comprehensively examine language among PM carriers in
comparison to healthy controls. Without such data, this severely limits our ability to (a) fully understand the impact
of the FMR1 PM, (b) examine cognitive correlates implicated in FXTAS (i.e., executive dysfunction), and (c)
understand the implications of language use and executive dysfunction on quality of life. This proposal addresses
these limitations with three aims: 1) Examine pragmatic and lexical-semantic language among male and female
PM carriers in comparison to healthy age- and sex- matched controls; 2) evaluate interactions of age and
executive functioning on language; and 3) assess interactions between language and executive function on
quality of life. This study will be completed virtually with a cross-sectional sample of 60 PM carriers (30 males,
30 females) without FXTAS and 40 healthy age- and sex-matched controls (20 males, 20 females) between the
ages of 35-55. Participants from across the U.S. will be recruited. Participants will complete virtual language
elicitation and executive function tasks, and self-report measures of executive function and quality of life. Results
from this proposal are expected to inform the nature of language differences among PM carriers compared to
controls. It is also expected that age and executive function will interact to adversely influence pragmatic and
lexical-semantic language in PM carriers but not controls, which would implicate potential neurocognitive decline.
Finally, we anticipate that poorer language and executive functions will adversely affect quality of life among PM
carriers. This proposal is consistent with the mission of the National Institutes of Health to enhance health and
reduce disability by expanding our understanding of a neurodegenerative condition associated with a common
genetic variant, the FMR1 PM. It also contributes to the strategic mission of the National Institute on Deafness
and Other Communication Disorders by informing knowledge on the basis of language impairments among
individuals with neurodegenerative disorders and links with quality of life.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will contribute to our understanding of the basis of language impairments among individuals at high risk for neurodegenerative disorders, as well as links between language, executive functions, and quality of life. This study will examine language production in a cross- sectional sample of adult males and females with the FMR1 premutation and healthy matched controls, and in relation to a key cognitive domain among premutation carriers - executive function. Given the prevalence of the FMR1 premutation (females: 1/~150, males: 1/~470), this work has the potential to expand our understanding of candidate language markers associated with an FMR1-associated neurodegenerative condition (i.e., FXTAS) and the phenotypic scope of the FMR1 premutation, thus informing links between genetics and language.